Johns Hopkins Institute for Clinical and Translational Research

Contact PD/PI: Ford, Daniel Ernest
The Johns Hopkins Institute for Clinical and Translational Research (ICTR) has been a productive, innovative
and impactful organization in transforming how clinical and translational research is conducted throughout
Johns Hopkins University. Enhancing collaborative research teams, advancing informatics, promoting new
methodologies, providing access to regulatory support, and bringing researchers and the community closer
together as true partners in discovery have all made translational research more successful. Over the next five
years, the Johns Hopkins ICTR will move beyond its current research community to create a comprehensive
regional hub that includes new partners – the University of Maryland Baltimore (UMB), Morgan State University
(MSU) and Kaiser Permanente Mid-Atlantic States (KPMAS). These partners bring complementary expertise
and connections to distinct populations. Together, we have an opportunity to conduct high quality innovative
research, and rapidly implement findings that impact the health of our state and region. Building on our
extensive connections with community groups, we will move to a new phase of joint governance with
bidirectional communication and participation on key ICTR committees. New programs will include a Trial
Innovation Unit that will focus on improving methodologic and operational support for research teams
conducting randomized clinical trials so that the impact of these trials is enhanced. A goal of this Unit will be to
pilot and disseminate approaches that move randomized clinical trials closer to the precision medicine
paradigm, with a focus on outcomes of greatest value to individual patients. Combining drug discovery
scientists at Johns Hopkins with experts at the UMB School of Pharmacy, the ICTR will create a new Drug
Discovery and Development Core. KPMAS and Johns Hopkins will continue to jointly fund programs that push
the boundaries of how a Learning Health Care system can improve health outcomes. The ICTR provides a
model for training investigators to work in multidisciplinary teams with experienced mentors using the most
rigorous methodologies. We will enhance our training programs by incorporating principles of biodesign from
the engineering tradition into the experience of all trainees. This places a higher emphasis on identification of
the problem, engaging important stakeholders (clinicians, patients, IT professionals) to develop solutions, and
identifying the most effective pathways to dissemination. Translational research demands the skills of many
professionals working together to address complex problems. The Johns Hopkins ICTR is poised to leverage
our current services to benefit new partners who have extensive responsibility for the conduct of research and
health care delivery in Maryland. Working together, we expect to have a measurable impact on translational
research in Maryland.
Page 679
Project Summary/Abstract
Contact PD/PI: Ford, Daniel Ernest
By identifying and overcoming barriers in the translational pathway, increasing scientific collaboration,
providing consultative services, clinical infrastructure, and technology cores that bridge the gap between the
laboratory and the clinic, the ICTR helps to speed the pace of scientific discovery, bringing effective therapies
to the public, and ultimately improving the health of Americans.
Page 680

Public health relevance
By identifying and overcoming barriers in the translational pathway, increasing scientific collaboration, providing consultative services, clinical infrastructure, and technology cores that bridge the gap between the laboratory and the clinic, the ICTR helps to speed the pace of scientific discovery, bringing effective therapies to the public, and ultimately improving the health of Americans.